Incorporating Donor Lung CT Images into Machine Learning Models to Predict Severe Primary Graft Dysfunction after Lung Transplantation

PROJECT SUMMARY/ABSTRACT
Primary graft dysfunction (PGD) is a form of acute lung injury that occurs in the first 72 hours after lung
transplantation. PGD is the leading cause of morbidity and mortality in the first 30 days and is strongly associated
with an increased risk of chronic rejection and death beyond the first year after transplantation. Donor, recipient,
and surgical risk factors for PGD have been identified, and clinicians make decisions about donor offer
acceptance based on these risk factors to avoid severe PGD. However, how different donor and recipient risk
factors interact to impact the risk of PGD is unclear. We previously built a machine learning (ML) algorithm to
predict the risk of severe PGD using clinical data available at the time of donor offer. However, this model was
based on single-center data, and its performance could be improved by capturing additional key parameters
using a multi-center cohort. Furthermore, the model did not include donor lung CT images through imaging is a
cornerstone of clinical decision-making. We hypothesize that donor lung CT images encode valuable information
that could be used to estimate the risk of severe PGD and that better risk estimates could be achieved by fusing
donor and recipient clinical data with donor CT imaging data. To test this hypothesis, we will perform an
observational study at five lung transplant centers in the US. We will use a retrospective cohort of bilateral lung
transplant recipients from the sites to build ML models to predict severe PGD, and concurrently, enroll lung
transplant recipients in a prospective cohort, which will serve for model validation. To determine the
characteristics of donor CT images associated with severe PGD, we will use the attention-based multiple
instance learning (MIL) method. We will divide CT scans into 3D patches of 32×32×32 voxels per patch, and
severe PGD will serve as the pseudo-label for all 3D patches. Both the original CT scans and the augmented
sub-volumes will be processed through separate Swin Transformer encoders and combined into three “heads”
used to compute the inpaint loss, contrastive loss, and bounding box detection loss. Gradient-weighted class
activation mapping (Grad-CAM) will be applied to the attention scores of the 3D patches to visualize prioritized
lung regions. Attention masks generated by the MIL model will be examined by a thoracic radiology expert to
identify and list imaging biomarkers predictive of severe PGD. We will then integrate the clinical and imaging
data using a multimodal learning strategy. The clinical and MIL-identified featuresets will be aligned using
separate Multi-Layer Perceptron (MLP) layers before concatenation and passed through another series of MLP
layers. To avoid overfitting, clinical and MIL-identified features will be combined in an element-wise fashion with
their independent feature vectors before being passed through the final MLP layers. This project will develop a
multi-dimensional clinical decision-making tool to predict the risk of severe PGD. This can enhance donor-
recipient matching and clinical preparedness for immediate post-transplant care to improve early outcomes after
lung transplantation.

Public health relevance
PROJECT NARRATIVE Primary graft dysfunction is a serious complication early after lung transplantation that is associated with morbidity and mortality. In this project, we will build machine learning models to predict severe primary graft dysfunction based on donor and recipient clinical data and donor chest computed tomography (CT) scans. We will use innovative methods to integrate clinical and imaging data in machine learning models, which can be applied to other areas in medicine.